A chemical AI and data science platform for the identification and discovery of novel psychoactive substances

Project Abstract/Summary
–––––––––––––––––––––––––––––––––––––––––––––––––––––––––––––––––––––––––––––––––––––––––––––––––
Novel psychoactive substances (NPS), including synthetic cannabinoids, cathinones, benzodiazepines, and
opioids, are increasingly a cause of intoxications and fatalities and a major public health concern. Toxicological
laboratories are tasked with detecting NPS in clinical and forensic samples in order to diagnose intoxications,
direct medical treatment, and provide epidemiological data that informs public health responses. However, the
chemical diversity of NPS, and the rapid pace at which NPS appear on the illicit market, makes this a daunting
task. Because individual laboratories cannot realistically develop clinical assays for every NPS, there are gaps
even in the detection of known NPS. Meanwhile, the detection of unknown NPS remains a highly time- and
labor-intensive process that is performed primarily within highly specialized laboratories. To address these
issues, this project will develop a comprehensive NPS database and innovative artificial intelligence (AI) tools
to assist toxicological laboratories in identifying both known and unknown NPS. In Aim 1, we will assemble and
curate the most comprehensive data resource of known NPS in existence. In Aim 2, we will repurpose neural
network architectures that power widely-used language models to predict the structures of as-of-yet unknown
NPS likely to emerge on the illicit market in the future. Because mass spectrometry is the primary analytical
technique used to detect NPS within toxicological laboratories, we will then produce data resources that
facilitate the identification of both known and unknown NPS by mass spectrometry. Specifically, we will apply a
suite of computational and machine-learning tools to predict the mass spectrometric properties (e.g., MS/MS
and retention time) of both the known and unknown NPS that would be observed if these compounds were
present in a human tissue or biofluid. These data resources will be disseminated via an interactive web
application that is already widely used in the toxicological community, and via in silico databases that can be
integrated directly within existing NPS detection workflows by toxicologists without any computational training.
By enabling faster and more comprehensive NPS detection, these resources will enhance clinical diagnoses,
improve toxicological testing, and better equip public health systems to respond to emerging drug threats.

Public health relevance
Project Narrative ––––––––––––––––––––––––––––––––––––––––––––––––––––––––––––––––––––––––––––––––––––––––––––––––– Novel psychoactive substances (NPS, also known as ‘designer drugs’) are synthetic drugs designed to mimic the effects of controlled substances while avoiding drug control laws. Toxicological laboratories are tasked with identifying NPS in clinical and forensic samples in order to guide clinical decision-making and steer public health responses, but the chemical diversity of NPS and the rapid evolution of the NPS market makes this a daunting task. This research will develop a suite of data resources and artificial intelligence technologies to accelerate the identification of both known and unknown NPS by toxicological laboratories.